Improve the Meaning of Patient Reported Outcomes to Evaluate Effectiveness for Cardiac Care" (IMPROVE-Cardiac Care)

PROJECT SUMMARY
Cardiac conditions are the leading cause of morbidity and mortality globally. Over 400 million people are living
with cardiac conditions, and 18 million people die annually. In the U.S., coronary heart disease affects 18.2
million adults and heart failure affects over 6.5 million people, of whom over 30% are hospitalized for acute
exacerbations annually. Patient-reported outcomes provide healthcare professionals and patients with insight
into where patients are on the disease trajectory, both during routine management and during recovery from a
major clinical event. The overall goal of the Improve the Meaning of Patient-Reported Outcomes to eValuate
Effectiveness for Cardiac Care” (IMPROVE: Cardiac Care) study is to establish population and individual
minimally clinically important differences (MCIDS), which are the smallest improvement that is meaningful to
patients with cardiac conditions. In Aim 1, the investigators will establish MCIDs in patient-reported outcomes
for patients with coronary heart disease recovering from coronary artery bypass surgery, or with heart failure
recovering from a hospitalization. In Aim 2, the investigators will establish MCIDs in patient-reported outcomes
for patients with heart failure with preserved ejection fraction undergoing disease management in the ambulatory
setting. For both Aims 1 and 2, we will use three statistical approaches including: 1) anchor-based methods
(associated changes in PROs and clinical indicators, mean changes, receiver operating characteristics), and 2)
conditional anchor-based methods (using multivariate logistic regression). In Aim 3, investigators will determine
how patient-reported outcomes from patients with cardiac condition can inform clinical decision-making. Guided
by the Data-Frame Theory of Sensemaking, we will evaluate 60 patient and healthcare professional dyads
making clinical decisions using patient-reported outcome health information with: 1) video ethnography to
measure communication behaviors; and 2) reflexive interviewing based on videoed clinical encounters to
describe how patient-reported outcomes are incorporated into the sensemaking process. Overall, the IMPROVE:
Cardiac Care study will establish minimally clinically important differences that can be used to identify patients
who are not optimally recovering from a cardiac event, and use the MCIDs to target early interventions. The
investigators will also develop a novel framework for how patient-reported outcomes can be meaningfully
incorporated into clinical practice.

Public health relevance
PROJECT NARRATIVE The primary objective of this study is to identify degrees of change in patient reported outcome measures that matter for guiding changes in clinical management of cardiac conditions. We are evaluating changes in patient reported outcome measures for patients with heart failure and coronary heart disease that are associated with improvements in their condition. The results of this study will build evidence for clinically meaningful changes in patient outcome measures and will include a framework to integrate patient reported outcome information into shared decision making and communication between healthcare professionals and patients.